Continuous ketone monitoring with the use of SGLT2 inhibitors in T1D

Applicant: Ahmad Haidar
Project Summary: Abstract
Diabetic ketoacidosis (DKA) is still a life-threatening risk in type 1 diabetes (T1D) that can occur
with acute illness or insulin interruption. Currently, the only means to monitor this risk are capillary
or urine testing, which provide few measurements only prompted by symptoms of the patient, or
by monitoring for high glucose levels with continuous glucose monitoring, which do not always
correlate with ketosis.
Sodium-glucose-linked cotransporter 2 (SGLT2) inhibitors are a group of anti-hyperglycemic
medications that have been shown to have cardiovascular and renal benefits, and reduce all-
cause mortality in those with and without diabetes. These medications, when studied in T1D,
increased risk of euglycemic DKA except with empagliflozin 2.5 mg, which had no renal benefit in
post-hoc analyses. Despite the risk, their off-label use in T1D remains common worldwide.
A continuous ketone monitor (CKM) has the potential to revolutionize the safety around ketosis
management. A sensor that alarms at increasing levels of beta-hydroxybutyrate can allow for
immediate action to prevent DKA from occurring. It can also provide useful information on normal
biochemistry with SGLT2 inhibitor use in T1D.
We aim to conduct a 2-part outpatient study, assessing the use of CKM to reduce ketosis and
DKA while using SGLT2 inhibitors. In Part 1A, 24 participants with T1D will use a CKM and be
given empagliflozin 2.5 mg for four weeks then empagliflozin 10 mg for five weeks. Participants
will perform an exercise challenge during the fourth week of empagliflozin 10 mg use and be on a
low-carb diet during the last week of empagliflozin 10 mg use. From this study, CKM data and
participant characteristics will be collected to better understand how changes in ketone levels are
affected by varying doses of empagliflozin, and which metrics help predict ketosis and DKA. Using
this data, we will refine our CKM algorithm that aims to (1) prevent DKA in people with T1D on
empagliflozin, and (2) identify which individuals can continue safely on higher doses of
empagliflozin. Moreover, we aim to develop educational guidelines pertaining to the general use of
the CKM system, and its use in managing DKA risk, exercise, and low-carb diets. Part 2 will be a
6-month study where 72 participants with T1D will use a CKM and be given empagliflozin at
escalating doses until they reach their maximum tolerated dose, as determined by our refined
algorithm. Education will be provided using the educational guidelines developed in Part 1, and
the efficacy of our refined algorithm will be assessed. The goal of our work is to provide a safe
way for people with T1D to use SGLT2 inhibitors.
Page 1 of 1

Public health relevance
Applicant: Ahmad Haidar Project Narrative This 2-part study aims to refine our previously developed algorithm for using a continuous ketone monitor (CKM) in people with type 1 diabetes (T1D) to mitigate DKA risk while taking SGLT2 inhibitors. The first part of the study will involve a 9-week trial in 24 participants with T1D using CKM with empagliflozin to gather data to fine-tune our algorithm. The second part of the study will comprise a trial in 72 people with T1D using CKM alongside empagliflozin for six months to use our algorithm to prevent DKA and provide personalized SGLT2i dose recommendations. Page 1 of 1